PROFESSIONAL SUPPORT FOR CANCER CONTROL AND POPULATION BASED RESEARCH NIH/NCI/DCCPS SURVEILLANCE RESEARCH PROGRAM

This contract provides support for the activities related to: cancer data collection, quality control, analysis, dissemination of reliable population-based cancer statistics, geospatial data systems, statistical modeling and other novel methodological and technological solutions relevant to cancer surveillance.